Academic-Industrial Partnership to Develop Clinical Tools for Algorithmic Irreversible Electroporation of Inoperable Tumors

Project Summary / Abstract
An estimated 100,000 patients are diagnosed with primary liver or pancreatic cancer per year with an even larger
number of patients will developing liver metastasis. Unfortunately, the vast majority of these patients are not
candidates for surgical resection, which is the only reliably curative treatment, yielding a five year survival rate
of approximately between 10 and 20% for patients with primary disease. The clinical challenge is that most
tumors form deep within organs, near major blood vessels, bile ducts, or nerves which complicate surgical
removal. Algorithmically Controlled Electroporation (ACE) is a new minimally invasive technique invented by the
PI for the treatment of inoperable tumors. This treatment uses brief electrical pulses to destabilize the cell
membrane and induce a tunable combination of necrotic and apoptotic cell death. We have validated the anti-
cancer efficacy of ACE against in vitro models, small animal tumor models, and in over 80 veterinary clinical
cases. In this Academic-Industrial Partnership proposal we will transition this validated technology from bench
to bedside through the development of a clinical instrument and matching disposable applicators. This
instrumentation will be validated in a porcine liver model to generate data necessary for 510(k) regulatory
submissions. The anti-tumor efficacy of the new system will then be demonstrated in a cohort of 22 canine liver
cancer patients admitted to the NCSU College of Veterinary Medicine. Data from this study will support premarket
approval (PMA) regulatory submissions targeting an oncology indication and provide the necessary data to justify
human clinical trials. To accomplish these goals we have assembled a multi-disciplinary team of biomedical
engineers, immunologists, veterinarians, hepatobiliary pathologists, and interventional oncologists. Development
work for the clinical system and the disposable applicators will be completed by two industrial partners: Gradient
Medical Inc. and Nocturnal Product Development LLC. These partners have extensive experience in the
development of pulsed electric field devices, commercialization of Class I, II, & III medical devices, quality
systems management (GMP/GLP) as well as CE, 510(k), and PMA regulatory submissions. The proposed work
will result in the development of a complete medical device suitable for clinical trials and commercialization along
with the data necessary to support submission of FDA regulatory filings. This work will be accomplished via four
specific aims: (1) Characterization of Metrics for Real Time Treatment Monitoring, (2) Design and Validate
Clinical ACE Pulse Generation System Suitable for Regulatory Evaluation, (3) Characterization of ACE
Treatments In a Large Animal Clinical Model, (4) Evaluate Safety and Efficacy of ACE Against Spontaneous
Canine Hepatocellular Carcinoma.

Public health relevance
Relevance to Public Health While there have been many advances in the treatment of liver cancer over the past half century, approximately 85% of patients with this disease will die within five years of diagnosis. Algorithmically controlled electroporation (ACE) is a new cancer therapy which uses ultrashort electrical pulses designed for the treatment of inoperable liver cancers. This Academic-Industrial Partnership proposal aims to develop the instrumentation and protocols necessary to translate ACE to the clinic and demonstrate the safety, efficacy and reproducibility of the treatment in a relevant spontaneous large animal model of disease.